fMRI Measures of Central Sensitization in Migraine

DESCRIPTION (provided by applicant): Application in response to: NOT-OD-09-058: NIH Announces the Availability of Recovery Act Funds for Competitive Revision Applications PUBLIC HEALTH RELEVANCE: Application in response to: NOT-OD-09-058: NIH Announces the Availability of Recovery Act Funds for Competitive Revision Applications.

Public health relevance
Application in response to: NOT-OD-09-058: NIH Announces the Availability of Recovery Act Funds for Competitive Revision Applications